NEWBORN SCREENING--INFECTIOUS DISEASE ASPECTS OF CYSTIC FIBROSIS

The identification of newborns with cystic fibrosis by the serum immunoreactive trypsinogen assay provides a unique opportunity to study early bacterial colonization and infections in CF.